A Randomized Controlled Trial to Improve Biobehavioral Regulation Among High-Adversity Mothers and Young Children

Project Summary
This Mentored Patient-Oriented Research Career Development Award (K23) will support the candidate to de-
velop skills to launch an independent research career as a translational clinical researcher focused on parent-
child interventions to address intergenerational transmission of mental illness in contexts of adversity. The
physical and intellectual research environments at Tulane University are supportive of professional develop-
ment in the areas of intergenerational stress and adversity, mechanistic measurement, and clinical research.
Training goals include: 1) Develop clinical trials research design skills; 2) Integrate mechanistic approaches
into clinical trials research with high-risk families; and 3) Develop basic competencies in deployment-focused
interventions. Adverse childhood experiences (ACEs) are significant risk factors for psychopathology across
the lifespan – risks that extend to the next generation, likely transmitted through both biological and behavioral
pathways. Biobehavioral self-regulation and parenting are key candidates for transmission and potential points
of intervention. However, nearly all intervention research takes a one-generation approach, measuring out-
comes in the individual adult or child in treatment. Additionally, very little research has examined biomarkers of
self-regulation in parents or children following treatment, and no known research has examined these pro-
cesses in parents and young children simultaneously across treatment to explore bidirectional effects. There is
a critical need to specify targets of two-generation interventions among high-adversity families to decrease in-
tergenerational transmission of mental illness. The objective for this K23 application is to determine whether
Mom Power, an evidence-based two generation intervention for mothers with histories of trauma, enhances
physiological and behavioral self-regulation in mothers and young children, testing mechanisms and examining
bidirectional effects. The central hypothesis is that the intervention will shift behavioral and physiological (Res-
piratory Sinus Arrhythmia) self-regulation in mothers, children, and dyads to mitigate psychopathology risk.
Three specific aims are proposed: 1) I will examine intervention effects on children's biobehavioral self-regula-
tion and psychopathology; 2) I will examine intervention effects on mothers' biobehavioral self-regulation, psy-
chopathology, and parenting behavior; and 3) I will examine intergenerational change processes, including
shifts in dyadic physiological and behavioral synchrony as well as bidirectional influences between mother and
child self-regulation. Consistent with a Research Domain Criteria (RDoC) perspective, self-regulation will be
assessed via self-report, behavior, and physiology in mothers and children. Findings will be used to support an
R01 application. The proposed award is significant because it is expected to provide an evidence-based, tar-
get-driven framework for the continued development and specification of parent-child interventions to prevent
intergenerational transmission of mental illness among high-risk families, while at the same time enabling the
candidate to achieve independence as a translational clinical researcher.

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health because it takes a mechanistic and experimental approach to understanding the intergenerational transmission of risk for mental illness among high-adversity families, seeking to identify targets and effects of intervention across two generations. Aligned with Strategic Objective 3 (strive for prevention and cures), this study employs a target-focused strategy probing the potential mechanism of deficits in self- regulation associated with stress-related mental health disorders in a high-risk population, examining effects in both high-risk mothers and their children. In line with NIMH's Strategic Objective 1 and a Research Domain Criteria (RDoC) multilevel, experimental therapeutics focus, the proposed research will evaluate self-regulation target engagement of the intervention in parents, children, and the dyad at multiple units of analysis, including physiology, behavior, and self-report.